The nuclear Ferredoxin reductase and its role in tumor suppression

Project Summary/Abstract
We and others showed that ferredoxin reductase (FDXR), a mitochondrial flavoprotein, is induced by
DNA damage in a p53-dependent manner and regulates apoptosis induced by reactive oxygen species.
As the only human ferredoxin reductase, FDXR receives two electrons from NADPH and transfers them
one at a time to its cognate substrates ferredoxin 1 (FDX1) and FDX2 and subsequently, plays a role in
biogenesis of steroids and iron sulfur cluster proteins. Despite these well-defined biochemical
functions, the role of FDXR in tumor suppression is still poorly understood. Interestingly, recent studies
showed that FDXR is the most consistent acute sensor following DNA damage, suggesting that FDXR
plays a role in DNA damage response and repair. Indeed, our pilot studies showed that FDXR is also
expressed in the nucleus and regulates cell growth and survival potentially via its nuclear substrates
(p53, Mdm2, and Mdm4) in response to a stress. These observations prompt us to hypothesize that the
nuclear FDXR has a critical biological function in tumor suppression. To further test this, two specific
aims are proposed: (1) To determine how FDXR subcellular localization is regulated; (2) To determine
how the nuclear FDXR exerts its biological function.

Public health relevance
Project Narrative The proposed study is highly significant and relevant to human health: (1) this study would provide better understanding of the FDXR biology and elucidate how FDXR mediates tumor suppression function via modulating p53/Mdm2/Mdm4; (2) this study will reveal a novel function of nuclear FDXR, which modulates redox signals in response to DNA damage response and repair (3) This study will characterize how FDXR activity is modulated via posttranslational modifications.